10X Chromium Connect for Single Cell Library Preparations for Translational Research

PROJECT SUMMARY/ABSTRACT
Funds are requested to purchase a 10X Genomics Chromium Connect to meet the ongoing and future
demands of numerous researchers within the Moores Cancer Center (MCC) and the School of Medicine at the
University of California, San Diego. The requested 10X Genomics Chromium Connect is a one-of-a-kind robotic
platform that automates single cell sequencing workflows by integrating single cell partitioning, barcoding, and
RNA library preparation together into one optimized solution that reduces workflow time and lowers the threshold
for performing single cell sorting and sequencing. Single cell sequencing is rapidly becoming a powerful tool
in basic, translational, and clinical cancer research, as well as in the study of other clinical disorders. The
depth of knowledge gained using single cell technologies is transforming the speed at which new therapies
for cancer and other diseases can be developed and fine-tuned. The 10X Genomics Chromium Connect
platform simplifies single cell sequencing workflows and lowers the threshold for performing single cell
sorting and sequencing for all users, especially when coupled with ready access to experts in both the
design of single cell experiments and the analysis of generated sequencing data. This device reduces
sample to sample variability and avoids human pipetting errors, thus adding substantial reliability to
sequencing data collection from run to run. The enhanced capabilities of the Chromium Connect over
current instrumentation available in San Diego will provide greater access to single cell sequencing
technologies to MCC users and thereby will advance cancer prevention, diagnosis, and care.
Our NIH funded users study a variety of projects, ranging from analysis of the tumor microenvironment,
tumor immunology, cell signaling, cancer stem cell biology, cancer therapeutics, and cancer care,
representing a wide variety of approaches to the study of cancer and cancer therapy. These projects span
basic, translational, and clinical cancer research. In addition, some of our MCC investigators conduct
research in other significant areas of disease biology. All have in common that high throughput, robust single
cell sequencing workflows will enhance their research by enabling more reliable single cell sequencing runs and
by eliminating barriers to the incorporation of single sequencing into their NIH funded studies.
The Chromium Connect will be located, administered, and maintained in the new Single Cell Processing
Shared Resource on the third floor of the Moores Cancer Center – a shared resource that will offer automated
single cell sequencing, single cell sorting for live cell assays, and digital spatial profiling - all technologies that
are needed for advanced cancer research. The Chromium Connect will participate in the MCC cost recovery
system to ensure partial recovery of funds for salaries, maintenance agreements, and supplies.

Public health relevance
PROJECT NARRATIVE Single cell sequencing has become a powerful tool in basic, translational, and clinical cancer research and as well as in other areas of biomedical research. The availability of automated, high throughput single cell sequencing workflows, coupled with access to significant expertise in experimental design and data analysis, will lower the threshold for performing single cell sequencing, thereby advancing research in cancer prevention, diagnosis, and care. The purpose of this application is to obtain funding to purchase a new state-of-the-art instrument, the Chromium Connect, to meet the of our leading investigators who work at the forefront of modern biomedical research that is aimed at aimed gaining insights into mechanisms regulating the microenvironment, immune response, cell signaling and stemness in cancer and other diseases.